Project 2: Intratumoral PDT Induces PDP-based Enhancement of PD-1 Inhibition in Pancreatic Carcinoma

ABSTRACT - Project 2
Pancreatic ductal adenocarcinoma (PDAC) is one of the deadliest malignancies and typically presents at
advanced stages. Progress in treating these cancers has been slow and has produced only very modest
increases in survival. One of the few positive developments has been the use of immune checkpoint inhibitors
(ICI) in the setting of PDAC with microsatellite instability (MSI). Unfortunately, MSI is uncommonly found in
these cancers. The goal of this project is to expand the usage of ICI to the majority of PDAC tumors by
stimulating the immune system via photodynamic priming (PDP) of the primary tumor, using the intravenous
photosensitizer Verteporfin which is activated by light delivered via an optical fiber delivered though a fine
needle into the tumor under endoscopic ultrasound or CT guidance. This initiates PDP, a process that
activates immune cell recruitment into the tumor and educates T-cells to mount a response against the
primary PDAC as well as peripheral metastasis. We had a patient in whom a pulmonary metastasis regressed
after PDP treatment of the primary cancer, without any additional chemotherapy or immunotherapy. In
addition, we were able to show an increase in tumor-directed T cells (responsive to ICI) in the peripheral
blood of another patient 72 hours after we administered PDP for pancreatic cancer. In Project 2, we will
perform a Phase II study using combination therapy with PDP (Veteporfin and red light) followed by ICI
(pembrolizumab). Aim 1 will assess this combination treatment in 25 patients with locally advanced or
advanced pancreatic cancer (oligometastasis), for its ability to increase overall and disease specific survival,
produce necrosis of the primary tumor and regression of metastatic disease; we will also monitor for any
toxicities. Dosimetry for PDP will be based on vascular perfusion of the tumor on CT scans as well as
fluorescence measurements from the buccal mucosa (with Core C), avoiding direct measurements in the
tumor which were found to be unreliable previously. Aim 2 will use a PDP radiometric index (found in residual
tumor after PDP) to predict response to ICI. The index is based on changes in tumor characteristics related to
the degree of inflammatory infiltrate that is reflected in tumor heterogenity. We will also use hyperspectral
fluorescence microendoscopy to evaluate lymphocytes from lymph nodes with metastatic disease
involvement (Core B), to determine if this correlates with the subpopulations found by flow cytometry. Finally,
Aim 3 will focus on PDP-stimulated immune cell changes in peripheral blood lymphocytes of our PDAC
patients, to determine if these changes correlate with post-PDP changes in lymphocyte sub-populations
observed after PDP in skin tumors (Project 1) that are known to be immune sensitive (squamous cell cancer)
and those that are not (basal cell cancer). Finally, in a group of 5 patients we will be sampling large metastatic
lymph nodes 3 days after PDP to assess the changes in immune cells, in order to determine whether ICI
responsive tumor directed T-cells will increase.

Public health relevance
NARRATIVE – Project 2 Pancreatic cancer is a deadly disease that is very resistant to chemotherapy, partly because the tumor is encased in a fibrous shell that helps the cancer disguise itself from the body's immune system. The purpose of this project is to create an immunologically-based treatment that first damages the primary pancreatic tumor using a light activated drug that disrupt the fibrous shell (allowing chemotherapeutic treatments to reach the cancer), and also causes the tumor to release damage signals that permit the patients' own immune system to identify and attack the cancer. This research could help immune-activating drugs (currently ineffective on their own) to become more effective for treating pancreatic cancer, both the primary lesions as well as distant metastases.